Integrative Multiomics and Clinical Laboratory Translation for Advanced, Rare, and Pediatric Cancers

ABSTRACT
The project aims to incorporate emerging technologies in genomics, transcriptomics, epigenomics and
proteomics for the analyses of advanced, rare, and pediatric cancers. The project has an additional
emphasis on translating the results from these new approaches into clinically actionable information
through the development of reportable test results in a CLIA clinical testing lab. The proposal will
leverage the capabilities and resources of the Mi-OncoSeq CLIA precision oncology lab, first
established in 2013. The Mi-OncoSeq lab has sequenced over ten thousand patient samples to date
with integrated analyses of tumor RNA, tumor DNA, and matched normal DNA.
This project will incorporate long-read and methylation sequencing, using Nanopore technology as a
complement to the existing panel of assays available based on Illumina short-read technology. The
laboratory operates a Promethion 24 from Oxford Nanopore in pursuit of these goals. The laboratory
is developing improved and accelerated bioinformatic pipelines for use in clinical testing labs. Overall,
these new technologies and analytical methods will be applied to our cohorts of advanced, rare and
pediatric cancers for improved clinical reporting to aid diagnostic, prognostic, and therapeutic decision-
making. Specific areas of research will include the roles of imprinting, structural rearrangement,
intergenic mutation, and promoter swapping in the development of these cancers and their mechanisms
of therapy resistance.

Public health relevance
Project Narrative This project entails the incorporation of new and emerging genomic, transcriptomic, and epigenomic technologies into cancer research and clinical testing programs. The generation and analyses of multiomic data in clinical cohorts of advanced, rare, and pediatric cancer cohorts is proposed. These advances in precision oncology will improve the discovery of actionable targets, diagnosis, and characterization of resistance mechanisms for cancer patients.